Racial and ethnic disparities in patient outcomes and intra-arrest resuscitation practices for in-hospital cardiac arrest

ABSTRACT
The overarching goal of this R21 grant proposal is to evaluate racial and ethnic disparities in patient outcomes,
racial and ethnic differences in the three key intra-arrest interventions (time to shock delivery; time to
epinephrine administration; time to termination of resuscitation), and quantify the impact of the racial and ethnic
differences in time to return of spontaneous circulation (ROSC) on outcomes disparities among adult patients
with in-hospital cardiac arrest (IHCA) using the American Heart Association Get With The Guidelines–
Resuscitation (GWTG–R), a multicenter prospective quality improvement registry of IHCA in the United States.
IHCA is a critical public health issue, affecting approximately 292,000 Americans annually. Despite various
efforts, the mortality after IHCA remains high, and only 18.8% of patients survive to hospital discharge,
highlighting its significance in the nation. Prior studies reported racial disparities in patient outcomes following
IHCA, with Black patients experiencing unfavorable outcomes than White patients. However, little is known
about outcomes among Hispanic patients compared with Black and White patients. Moreover, the underlying
mechanisms of racial disparities between Black and White patients remain unclear. Racial and ethnic
differences in intra-arrest resuscitative interventions are the potential source of the health inequity. Evaluating
racial and ethnic disparities in intra-arrest resuscitative interventions will enhance our understanding of these
potential disparities in the process of care and identify modifiable areas for improvement in IHCA care. We will
investigate three crucial intra-arrest resuscitative interventions: time to shock delivery, time to epinephrine
administration, and time to termination of resuscitation (TOR)—all are directly linked with patient outcomes.
To fill the crucial gaps in knowledge and mitigate the health inequity in IHCA, we will investigate patients’ racial
and ethnic disparities in time to ROSC, survival to hospital discharge and favorable functional outcome at
hospital discharge across Hispanic, Black, and White patients (Aim 1); evaluate patients’ racial and ethnic
differences in time to shock delivery (Aim 2A), epinephrine administration (Aim 2B), and TOR (Aim 2C); and
quantify the impact of racial and ethnic differences in time to ROSC on racial and ethnic disparities in survival
and favorable functional outcome after IHCA using causal mediation analyses (Aim 3).
In our project, we will employ IHCA as a representative case for emergent conditions, with the objective of
evaluating racial and ethnic disparities in outcomes and intra-arrest practices. We anticipate that our study will
identify specific areas where interventions can be implemented to mitigate the health inequity in IHCA.

Public health relevance
PROJECT NARRATIVE In-hospital cardiac arrest is a significant public health concern, affecting approximately 292,000 Americans each year, with a survival rate to hospital discharge as low as 18.8%. Although Black patients exhibit a lower survival rate than White patients, the reasons for this health inequity remain unclear. This proposal aims to evaluate racial and ethnic differences in patient outcomes and intra- arrest care processes in order to identify specific areas that can be improved to mitigate the health inequity following in-hospital cardiac arrest.